Stanford Aging & Ethnogeriatrics Transdisciplinary Collaborative Center (SAGE)

PROJECT SUMMARY—OVERALL COMPONENT:
The NIH has long recognized the necessity to aggressively leverage emerging methodologies like precision medicine,
digital health, biomedical data science and virtual reality & simulation based interventions approaches to ameliorate
health disparities in racial and ethnic minorities. However, relatively fewer efforts have attempted to conduct trans-
disciplinary aging research integrating biological, social and behavioral sciences utilizing emerging methodologies. The
overarching goal of the proposed Stanford Aging and Ethnogeriatrics Transdisciplinary Collaborative Center (SAGE) is to
increase the diversity of the aging research workforce by mentoring new leaders in aging research and promoting
advances in behavioral and social sciences aging research using emerging methodologies including precision medicine,
digital health, biomedical big data science and virtual reality and simulation based interventions. By identifying,
mentoring and supporting (through dedicated pilot funds and methodological and recruitment support) junior investigators
from underrepresented groups (SAGE Scientists) we propose to create a culturally sensitive and culturally competent
research workforce focused on promoting equity in healthcare and mitigating disparities in diverse older populations using
emerging methodologies. We have in place outstanding strengths in the three principal scientific elements requisite to
form a coordinated, sustainable, and far-reaching `aging research to practice collaboration' integrating behavioral, social
and biological sciences using emerging methodologies: 1) Behavioral and social scientists and disparities researchers,
spanning psychology, psychiatry, demography, epidemiology, evolutionary biology, health services research &
economics, computer science, social media science, virtual reality/simulation interventions and digital health; 2).
Extensive experience with trans-disciplinary translational research that integrates laboratory assessment of genetic
markers, their relationships to both disease risk and treatment relevance with psychosocial research approaches; and 3)
Novel and outstanding analytic and high-performance `big-data' computing capabilities, consolidated in our Department
of Biomedical (`Big Data') Data Science. With Stanford's setting in one of the most racially, ethnically and socially
diverse aging populations in the US, and leveraging the seven-school campus-wide “Precision Health” initiative that
integrates biomedical data science, engineering, business, design, digital health technology, virtual reality interventions
and patient care under the recently endowed Center for Population Health Sciences we feel uniquely situated to make
game-changing breakthroughs in aging research using emerging methodologies, and to lead such research efforts
nationally.

Public health relevance
PROJECT NARRATIVE The Stanford Aging and Ethnogeriatrics Transdisciplinary Collaborative Center (SAGE) will advance health and mitigate health disparities in diverse older Americans by recruiting and training junior investigators from underrepresented groups to conduct transdisciplinary, aging research using a biopsychosocial framework and utilizing emerging methodologies.